INHALED DOSES OF IB-367 IN ADULT CYSTIC FIBROSIS PATIENTS

The purpose of this study is to investigate the safety and tolerability (the ability of the body to accept the medication) of several different doses of IB-367 administered via a nebulizer to patients with moderate cystic fibrosis lung disease. It is hoped that this study will help select the appropriate dose for further studies of IB-367 in patients with cystic fibrosis. Patients in this study will receive either IB-367 or a placebo (an inactive substance). The assignment to the treatment group is done on a random basis, and is determined before the study begins.